Investigating Impacts of Neighborhood Disadvantage on ADRD risks, imaging biomarkers, and cognition

PROJECT SUMMARY
An estimated 6.7 million Americans are living with Alzheimer’s disease (AD) dementia in 2023, with more than
55 million people living with AD worldwide. However, stark disparities exist in the prevalence of AD with older
adults with multidimensional poverty being more than twice as likely to develop dementia during their lifetime.
Resources, opportunities, and the environment where you live, work, play, and age, also known as the social
determinants of health, have been proposed as significant predictors of numerous risk factors associated with
dementia. This proposal will investigate the influence of a novel social determinant of health, neighborhood
disadvantage, on (1) cardiovascular and metabolic risk factors, brain imaging biomarkers, and (2) cognitive
function associated with AD and related dementias (ADRD). This project will utilize data from the Wake Forest
Alzheimer’s Disease Research Center (ADRC) Clinical Core Cohort to conduct analyses investigating these
relationships. Training will take place at the Wake Forest University School of Medicine in the Molecular
Medicine and Translational Science (MMTS) and Medical programs as a part of the M.D./Ph.D. dual-degree
program. The applicant will receive training in the foundational knowledge necessary to conduct health
disparities research, statistical methodology and analytical design, and scientific writing and communication to
accomplish the proposed aims. Mentorship for the proposal includes a multidisciplinary team with individuals in
the ADRC, along with faculty in the Internal Medicine and Neurology departments. This team will provide the
applicant with feedback every step along the way, regarding data analysis, interpretation of findings, and
manuscript preparation. The proposed aims have the potential to provide new insights into the effects of one’s
neighborhood-level disadvantage on various factors of risk associated with ADRD and further elucidate the
influence of social determinants of health on risk for dementia.

Public health relevance
PROJECT NARRATIVE The number of people who live with dementia, the impaired ability to remember, think, or make everyday decisions that interferes with daily activities, is increasing rapidly with some estimating a tripling of the number by 2050. With this increase in cases, existing disparities in who develops the disease will also continue to widen, with those living in poverty becoming more likely than they already are to develop dementia. This project will look at how where one lives might impact their risk for developing dementia, by considering the resources and opportunities that are available to them because of the neighborhoods they live in.